EFFECTS OF HYPOTHALAMIC-PITUITARY-ADRENAL AXIS ON DOPAMINE ACTIVITY IN MAN

The goal of this study is to compare the effects of corticotropin-releasing hormone(CRH), adrenocorticotropic hormone (ACTH) , hydrocortisone and placebo on dopamine activity in humans.